Identification of plasma lipoprotein proteins and lipids as biomarkers of innate-immunity and vascular contributions to Alzheimer's disease and Alzheimer's disease-related dementias in older adults

Project Summary. Critical needs exist to fully understand the complexity of Alzheimer’s disease (AD)
pathophysiology and more accurately characterize AD using biomarkers beyond amyloid, tau, and neuronal
injury (AT[N]). Vascular pathology substantially increases the risk of AD and AD-related dementias (ADRDs)
and coexists with AD pathology (brain amyloid deposition) in the majority of AD/ADRD cases.
Neuroinflammation underlies the development of both vascular and AD pathologies and is modulated by
peripheral factors that exacerbate or attenuate cognitive decline. Evidence suggests that plasma lipoproteins
influence the development of brain amyloid deposition and cerebral small vessel diseases and underlying
neuroinflammation, neurodegeneration, and AD/ADRD sequelae (cognitive decline and incident dementia).
The objective of this proposal is to identify protein and lipid cargo of plasma lipoproteins that are associated
with AD pathology, vascular pathology, neuroinflammation, neurodegeneration, cognitive decline, and incident
dementia in older adults. The central hypotheses are that plasma lipoproteins influence brain amyloid
deposition, vascular pathology, and neuroinflammation, and alter neurodegeneration and trajectories of
cognitive decline and incident dementia. This proposed study will employ already-collected plasma samples
and outcome data from the Atherosclerosis Risk in Communities Neurocognitive Study (ARIC-NCS). We
identified 743 eligible ARIC-NCS participants without dementia (mean age: 76.4 years) who had blood
collected at baseline and had baseline plasma measures of brain amyloid deposition (Ab 42/40 ratio, p-tau
181), neuroinflammation (GFAP), and neurodegeneration (NfL) available. These participants also had central
arterial stiffness and cognitive function and status evaluated at baseline, concurrent with the baseline blood
collection that we will use for our plasma lipoprotein fractionation, and had cognitive function and status
evaluated twice more over a mean follow-up period of 6.5 years. We will randomly select 346 participants and
fractionate their plasma samples, measure proteins and lipids in 1384 fractionated plasma lipoproteins (346 of
each fraction [VLDL, IDL, LDL, HDL]) using MS-based proteomics and lipidomics, respectively, and identify
proteins, lipids, or their interactions in plasma lipoproteins in relation to AD/ADRD-related outcomes. The
specific aims are: 1) Determine proteins or lipids in fractionated plasma lipoproteins as biomarkers indicative of
AD pathology and vascular pathology; 2) Establish proteins or lipids in fractionated plasma lipoproteins as
biomarkers suggestive of neuroinflammation and neurodegeneration; and 3) Identify proteins or lipids in
fractionated plasma lipoproteins as biomarkers predictive of cognitive decline and incident dementia. Our
proposal will broaden our perspective and understanding of peripheral factors in the development of AD/ADRD
pathophysiology and will identify potentially useful plasma lipoprotein–based therapeutic strategies and
biomarkers beyond the current AT[N] paradigm for treating or preventing AD/ADRDs.

Public health relevance
Project Narrative Critical needs exist to fully understand the complex set of changes in the body that contribute to the development of Alzheimer’s disease (AD), which now affects approximately 1 in 9 Americans aged 65 and older. We propose a large-scale analysis of already-collected blood samples from older adults that will examine common plasma components known as lipoproteins. This study will uncover previously unknown associations of the proteins and lipids found within plasma lipoproteins with AD development and progression, allowing us to identify new AD biomarkers related to the vascular system that can be used to develop new strategies for preventing or slowing the progression of AD or AD-related dementias.